RNASEH2B loss to predict response to PARP inhibitor in prostate cancer

ABSTRACT
Metastatic castration-resistant prostate cancer (CRPC) is an incurable disease that is expected to account
for ~ 31,000 deaths each year in the United States. There are limited therapeutic options for metastatic CRPC
patients that extend life. There is an urgent need for developing novel targeted therapies, especially
personalized therapies based on genomic alterations in tumors. Recent genomic studies have revealed a
variety of actionable molecular targets with underlying genomic alterations. Notably, alterations in genes
involved in DNA damage response (DDR) are among the most common genetic events and enriched in
metastatic CRPC. These alterations have been correlated with particular therapeutic vulnerabilities in prostate
cancer (PCa) cells. Specifically, defects in homologous recombination (HR) repair would predict sensitivity to
inhibition of Poly (ADP-ribose) polymerase (PARP). PARP inhibitors (PARPi) are a new type of targeted
therapy, which works by preventing the enzyme PARP from repairing damaged DNA in tumor cells. BRCA1/2
encode proteins essential for HR repair. Cancer cells lacking BRCA1/2 depend instead on PARP-regulated
DNA repair and are hypersensitive to PARPi. The U.S. FDA has approved two PARP inhibitors (olaparib and
rucaparib) for treatment of metastatic CRPC patients with HR repair mutations (or deleterious BRCA
mutations) based on the results from recent clinical trials.
One of the major barriers to effective treatment using PARPi is how to select patients who most likely
benefit from PARP inhibition. BRCA mutations can predict PARPi response with 50-60% accuracy. However,
the degree to which patients with non-BCRA genomic alterations respond to PARPi remains unclear. Through
a genome-wide CRISPR screen, we have recently discovered that loss of RNASEH2B in PCa cells may
predict response to PARP inhibition. RNASEH2B is one of the three RNase H2 subunits that are thought to
play a role in DNA replication. A recent study has demonstrated its function in ribonucleotide excision repair,
which may contribute to PARP-trapping lesions. Importantly, analysis of TCGA datasets revealed RNASEH2B
deep deletions in 17% of PCa tumors. Co-deletion of RNASEH2B and RB1 on chromosome13q14 frequently
occurs. In addition, the results from our CRISPR screening further suggest that loss of TP53 may render PCa
cells resistance to PARPi. Therefore, the goal of this project is to determine (1) to what extent loss of
RNASEH2B confers a cellular response to PARPi in preclinical PCa models; (2) to what extent inactivation of
TP53 and RB1 influences the response to PARPi. The successful implementation of this project will set the
stage for future clinical trials in PCa patients with RNASEH2B/TP53/RB1 alterations and significantly expand
the pool of eligible patients for PARP inhibition.

Public health relevance
PROJECT NARRATIVE One of the major barriers to effective treatment using PARP inhibitor is how to select patients who most likely benefit from PARP inhibition. In this project, we will determine whether loss of RNASEH2B can predict response to PARP inhibitor in prostate cancer.